MOLECULAR BIOLOGY OF THE PTERIN-DEPENDENT HYDROYXLASES ANCILLARY ENZYMES

Putative clones of human liver phenylalanine hydroxylase and dihydropteridine reductase (DHPR) have been isolated and are being characterized.